Research Supplement to Promote Diversity in Health-Related Research

The goal of this research supplement is to enhance the impact of the parent R01 by providing
an intensive, hands-on research experience to a highly motivated undergraduate student as the
student lays the groundwork for a career in the biomedical sciences. The research supplement
is designed to provide the candidate with critical experience in three areas: 1) Exposure to a
breadth of hands-on techniques described in the parent grant; 2) The chance to observe how
individual experiments and techniques are integrated to address a central question; and, 3)
Weekly practice and coaching in scientific communication. In addition, the candidate will be
provided with the mentorship, resources, and information necessary for her to make critical
early choices regarding further study. The aims of the parent grant will receive additional direct
benefit from the candidate assisting and performing experiments described in the research plan,
and as the candidate contributes intellectually to laboratory discussions.

Public health relevance
Pumping of the heart is generated by interactions between the thin and thick contractile protein filaments that make up cardiac muscle. Cardiac myosin-binding protein-C (cMyBP-C) is a thick filament component that regulates cardiac contraction in response to stimulation, and genetic defects in cMyBP-C result in heart failure and sudden death. Despite its importance, significant gaps in our understanding of cMyBP-C functionality remain. This proposal will define the molecular structure, function, and regulation of cMyBP-C. These studies and derived knowledge are precursors to the development of targeted therapies in order to correct the functional defects associated with genetic mutations to cMyBP-C.